"Plasma and cellular immune biomarkers of Kaposi's sarcoma in HIV-1 suppressed patients"

Abstract
Despite more than a decade of widespread antiretroviral therapy (ART) implementation, Kaposi’s sarcoma
(KS) remains the most common malignancy in people living with HIV-1/AIDS, in whom it causes significant
morbidity and mortality [1]. Beyond a requirement for KSHV infection, the mechanisms underlying KS
development are poorly understood. KS prevalence is high in people living with HIV-1 where it associates with
CD4+ T-cell depletion. Thus, CD4+ T-cell functional dysregulation has been suggested to lead to KS
development. Indeed, following successful ART, there is reconstitution of CD4+ T-cells [17] which often leads
to KS resolution. In contrast, KS in patients with high CD4+ T-cells and low HIV-1 PVL [4–7] have been
described, suggesting immune defects beyond CD4 T-cell reconstitution. In HIV-1 PVL suppressed patients, it
is possible that there exist quantitative or qualitative differences in CD4+ T-cells between patients that develop
KS and those who remain asymptomatic. These differences might limit the ability of CD4+ T-cells to provide
help to B-cells and cytotoxic CD8+ T-cell. Alternatively, CD4+ T-cells might be fully functional in HIV-1 PVL
suppressed patients but the defect is in the cytotoxic CD8+ T-cell compartment in those with KS. Chronic
antigenic stimulation could induce CD8+ T-cells to states of exhaustion or anergy making them non-responsive
to KSHV infected cells and KS tumors. Importantly, there are no biomarkers of KS control or its absence that
can be used to identify individuals that are high risk for KS despite HIV-1 control. Our group and others have
shown dysregulation of metabolic pathways in KS tumors [11–14]. Since altered metabolites often correlate
with disease, identification of plasma and or urine metabolites that differentiate HIV-suppressed patients with
and without KS could prove to be important KS biomarkers. Therefore, the objective of this proposal is to
recruit Tanzanian HIV-1 PVL suppressed patients presenting with KS at ORCI, and age and sex-matched co-
infected but asymptomatic controls from nearby CTCs in order to define immune responses and metabolomic
profiles that differentiate the two groups. The hypothesis is that, distinct metabolomic and immune responses
differentiate reconstituted HIV-1 suppressed patients experiencing KS from otherwise matched asymptomatic
controls. Transcriptional profiling of relevant immune cell subsets and metabolomics/proteomic analysis of
plasma and urine will provide mechanistic insight into the bases for the differential metabolomics/proteomics
and immune responses. Therefore, the proposed study has potential to identify biomarkers for KS diagnostics,
treatment management, or to identify potential immunotherapeutic or vaccine development strategies.

Public health relevance
PROJECT NARRATIVE This is the first study to comparatively investigate cellular immune responses and transcriptomes profiles, and associated plasma, and urine metabolomes/proteomes between Tanzanian HIV-1 suppressed patients with incident Kaposi’s sarcoma (KS) and age and sex-matched co-infected but asymptomatic controls to identify biomarkers of KS.